Mechanisms Underlying Seasonal Adaptation of Daily Behaviors

Daily wake-sleep cycles are a pervasive feature of animal life, and disruptions in sleep are associated with
numerous health related disorders in humans. The circadian timing system generally regulates the timing of
wake and sleep to specific times in the day depending on whether an animal is diurnal or nocturnal. In addition
to circadian regulation, daily wake-sleep patterns are governed by a complex balance between homeostatic
sleep promoting pathways, arousal circuits, environmental signals (e.g., light and temperature) and internal state,
such as nutritional status. In this proposal we will use Drosophila as a model system to understand how daily
wake-sleep cycles adapt to seasonal changes in environmental conditions, with an emphasis on the relatively
uncharacterized role of temperature. Temperature has been shown to have widespread effects on sleep in both
Drosophila and humans. For example, many diurnal animals respond to warm temperatures by increasing
daytime sleep or ‘siesta’, almost certainly an adaptive response to minimize exposure to heat. A major
foundation for our proposal is based on our long-standing work showing that in D. melanogaster the temperature-
dependent splicing of the 3'-terminal intron (called dmpi8) from the key circadian clock component termed period
(per) is a prominent ‘thermosensor’ that adjusts the distribution of daily wake-sleep cycles, eliciting seasonably
appropriate responses. For example, on warm days splicing of the dmpi8 intron is inefficient somehow leading
to a longer midday siesta. In more recent findings we showed that the thermosensitive splicing of dmpi8
modulates the distribution of daily activity via a non-circadian mechanism that involves changes in sensory-
mediated arousal. We will undertake a multi-faceted experimental strategy that includes biochemical, molecular,
cell-culture and whole animal approaches to characterize this novel arousal/sleep circuit.

Public health relevance
Daily wake-sleep cycles are governed by the interplay of numerous centers in the brain, including circadian, sleep and arousal pathways. The timing of daily changes in wake-sleep states can be seasonally adjusted to optimize when certain activities, such as sleeping or feeding take place. This proposal will investigate the mechanisms for how daily behavior is modulated by temperature, which has widespread effects on sleep quality and hence health in humans.